Clinical Research Support Services for NIEHS Contract Task Order 7 - Clinical Monitoring Activities

The purpose of this severable task order is to perform clinical monitoring services in support of specified NIEHS research studies.